Continuing the development of orthopaedic surgeon-scientist expertise in patient-oriented research

ABSTRACT
The overarching objective of this K24 renewal proposal is to leverage the increased protected research time
afforded by the K24 award to ensure intensive mentorship of promising surgeon-scientists, sustain ongoing
mentorship of surgeons within my clinical trials network, allow the completion of comparative effectiveness
exploratory analyses, and develop a clinical trial master protocol. Receiving the initial K24 grant provided me
with the protected time for research to achieve remarkable success in all four K24 objectives in the previous
award period. It allowed me the opportunity to develop the research careers of medical students, residents,
clinical fellows, graduate students, and early career surgeons. Additionally, I was able to focus on advancing
several other personal career goals crucial for my sustained growth as a scientist. In response to the
successes of the previous K24 award period and recognizing the increasing demand for mentorship from
aspiring surgeon-scientists, this proposal entails a substantial augmentation of K24 protected time, from 25%
to 40%. This K24 renewal application is of paramount importance to my commitment to supporting the new
generation of surgeon-scientists and advancing the field of fracture care research. This proposal aims to
strengthen my mentorship capabilities and generate novel avenues for my mentees to succeed in bolstering
their independent research careers. Specifically, mentees will 1) explore clinically important research questions
using high-quality data from the PREP-IT trials; 2) have immediate access to an established trial infrastructure
for new ideas supported by a master protocol; and 3) develop original research ideas to be continued in their
independent research careers. Over the duration of the award, I will concurrently develop my abilities as a
surgeon-scientist and mentor. These career development objectives include the following: 1) increase my
formal expertise in advanced research analysis techniques, and 2) expand my understanding of platform trials
and master protocols. In summary, this K24 renewal proposal is designed to empower the next generation of
surgeon-scientists by increasing my mentorship capacity, introducing novel research methods, and
streamlining clinical trial initiation. By investing in these objectives, I aim to strengthen the foundation of
fracture care research and positively impact patient care.

Public health relevance
NARRATIVE The overarching objective of this K24 Renewal proposal is to leverage the increased protected research time afforded by the K24 award to ensure intensive mentorship of promising surgeon-scientists, sustain ongoing mentorship of surgeons within my clinical trials network, allow the completion of comparative effectiveness exploratory analyses, and develop a clinical trial master protocol. This proposal aims to strengthen my mentorship capabilities and generate novel avenues for my mentees to succeed in bolstering their independent research careers. Specifically, mentees will 1) explore clinically important research questions using high-quality data from the PREP-IT trials; 2) have immediate access to an established trial infrastructure for new ideas supported by a master protocol; and 3) develop original research ideas to be continued in their independent research careers.